Novel macrophage and regulatory T cell interactions that promote the pathogenesis of Duchenne muscular dystrophy

Supplement Project Summary/Abstract Statement
The original Project Summary/Abstract has not changed as a result of the proposed supplement activities.

Public health relevance
Supplement Project Narrative Statement The original Project Narrative has not changed as a result of the proposed supplement activities.